Mechanisms of protection from, and enhanced susceptibility to, HIV infection afte

Enter the text here that is the new abstract information for your application. This section must be no E 0 longer than 30 lines of text. The key to understanding the results of the STEP/Phambili trials is first to model the results of the trial in controlled experiments using mucosal SIV inoculation of rhesus macaques. Thus, we will determine the effectiveness and potential of the Merck trivalent HIV adenovirus 5 vector vaccine (V520) for enhancing susceptibility to S1V in a rhesus macaque model of mucosal HIV transmission. If models of vaccine protection or enhancement are established, the immune mechanisms and inflammation/activation associated with any protective or enhancing effects can be defined in a renewal application. 0'Qvic' am- .,c vii

Public health relevance
RELEVANCE (See instructions): Understanding the reasons for the failure of the once promising Merck Ad5 HIV vaccine is critical before proceeding with additional HIV vaccine trials. Without a complete understanding of the failed STEP/Phambili trials, the next clinical trial of a HIV vaccine willl be truly empirical human experimentation rather than a rational next step in vaccine development. This we have proposed animal model studies to characterize the virologya nd immunology of the Step/pahmbili trials.